Understanding the Guideline-Discordant Use of Bone Modifying Agents in Prostate Cancer

PROJECT SUMMARY
Bone-modifying agents (BMAs) can improve quality-of-life in metastatic prostate cancer. The BMAs zoledronic
acid and denosumab prevent bone fractures among men with metastatic, castration-resistant prostate cancer
(mCRPC), resulting in reduced pain and improved function. However, BMAs can cause serious side effects.
Because BMAs do not prevent fractures among men with metastatic, castration-sensitive prostate cancer
(mCSPC), the risk/benefit balance does not support BMA use for these patients. For these reasons, the
National Comprehensive Cancer Network Guidelines recommend for the use of BMAs in mCRPC, and against
their use in mCSPC. Patient outcomes may therefore be adversely affected by both BMA underuse among
patients with mCRPC and by overuse among patients with mCSPC. However, little is known about the real-
world use of BMAs in prostate cancer. To determine whether BMA underuse and/or overuse are significant
problems, the utilization patterns of BMAs for prostate cancer must first be understood. BMA drugs also have
important differences in value – benefits relative to financial cost. Zoledronic acid is cost-effective, but
denosumab, which is much more expensive, is not. The use of denosumab instead of zoledronic acid may
therefore result in avoidable costs to patients and the health system. To address these knowledge gaps, we
propose to describe real-world use of BMAs in prostate cancer using SEER-Medicare data. We will identify two
key patient groups: those with mCRPC, among whom BMA use is recommended, and those with mCSPC,
among whom BMA use is discouraged and would constitute overuse. We will determine the prevalence of
BMA therapy within each group and characterize the patient and provider factors associated with underuse
and overuse. We will also assess whether increased denosumab use has resulted in excess financial costs to
patients or to Medicare. Aim 1: Measure the prevalence of underuse and overuse of bone-modifying
agents in prostate cancer. To measure potential underuse, we will use SEER-Medicare data to identify
patients with mCRPC and determine their receipt of BMAs (Aim 1A). To measure overuse (Aim 1B), we will
identify patients newly diagnosed with mCSPC and determine receipt of BMAs. Aim 2: Identify and describe
patient and provider factors associated with underuse and overuse of bone-modifying agents. We will
use SEER-Medicare data to identify key patient socioeconomic factors and provider organizational factors
associated with BMA underuse (Aim 2A) and overuse (Aim 2B). Aim 3: Evaluate changes in utilization of
denosumab and associated costs. We will assess temporal trends in the relative use of denosumab vs.
zoledronic acid (Aim 3A) and estimate resulting costs to patients and to Medicare (Aim 3B). Impact: This
study will increase our understanding of BMA utilization in prostate cancer. Study results may lead to future
interventional work to improve prostate cancer outcomes by reducing BMA underuse and overuse.

Public health relevance
PROJECT NARRATIVE Treatment with bone-modifying agents is beneficial for some groups of prostate cancer patients but harmful for others. Though this class of drugs is in widespread use, little is known about the extent of underuse among patients who would benefit from them or overuse among patients who would be harmed. We propose to quantify the prevalence of underuse and overuse of bone-modifying agents in prostate cancer, to inform the need for future interventional work to improve utilization.